BCCMA: VA Colorectal Cancer Clinical & Computational Collaborative (VA-5C): Project #2 - Artificial Intelligence and Multispectral Imaging of Colorectal Polyps.

Objectives: This BLRD-CSRD-Collaborative MERIT Award (BCCMA) application is comprised of
three projects unified by their focus on CRC precursors in Veterans. We, together with Los Angeles
and San Diego VA’s call our team-science consortium the “VA5C,” for VA Colorectal Cancer
Clinical & Computational Collaborative. Our multidisciplinary collaborative is linked by a common
focus on CRC precursors as targets for intervention. The overarching objective of this proposal is to
deploy and validate clinically an artificial intelligence (AI)-based low-cost platform to make endoscopic
prevention of colorectal cancer (CRC) more efficient. We seek to create an accurate and widely
adoptable, real-time histology (RTH) platform based on AI. Colonoscopic CRC prevention hinges
on the complete removal and histopathological assessment of all polyps. This practice results in the
removal of large numbers of polyps that have negligible malignant potential creating a need for tools to
assess histology in real time to decrease biopsy costs and risks. Professional societies now endorse the
purely optical management of small polyps and have put forth guidelines and performance thresholds
toward adoption. Application of AI to RTH should help to make operators more consistent and
accurate. For VA, such capability would finally open the door to widespread adoption of cost-
saving resect-and- discard and leave-behind paradigms for diminutive polyp management. Our
work on a Computer Aided Diagnosis (CADx) system that we call “EndoVet-AI” shows great
potential to be a widely adoptable, accurate RTH platform in VA for distinguishing hyperplastic
from adenomatous polyps. Sessile serrated lesions (SSLs), which are a distinct, visually subtle
precancerous type of polyp, have not been addressed directly. To this point, we hypothesize that AI
trained on SSLs will be capable of distinguishing their borders with reasonable accuracy. With this
backdrop, the broad aims of Project #2 are to (Aim 1) Grow and maintain a CRC image and video
database toward a formal curated VA-wide Image Repository for CRC-related AI research. (Aim 2)
Collaborate with machine learning experts to deploy and validate clinical CADx models that differentiate
benign serrated lesions (SLs) (e.g. hyperplastic polyps) from SSLs. (Aim 3) Pursue preclinical
translational research with San Diego to define the typically subtle borders of SSLs in
genetically engineered mouse models (GEMMs) using a multimodal mouse colonoscope
and fluorescence imaging of mucin antibodies. The ultimate goal is to translate work in GEMMs
combined with annotations of human SLs to develop AI-assisted segmentation to guide complete
resection of detected SSLs.
Methodology: We will (1) Create a Gastroenterology (GI) Image Data Repository which can house
still images, videos of complete colonoscopies, scanned digital pathology slides, and associated
procedure data; (2) initiate a multisite clinical study to acquire videos from patients at increased risk of
SSLs, then use that data to design and validate AI algorithms for RTH of polyps to include SSLs;
(3) develop preclinical translational AI models to delineate the indistinct borders of serrated lesions in
GEMMs; and (4) prospectively test new algorithms with the two other VA facilities in the BCCMA. The
primary endpoint of this last aim will be to evaluate the performance of CADx benchmarked against
performance thresholds per professional society guidelines.

Public health relevance
Among Veterans, colorectal cancer accounts for about 10% of all cancers. Despite advances in colonoscopy and high resection rates, local and distant recurrence remains a significant problem, as high as 40%. The potential benefit of this collaborative study is the improvement of early detection, diagnosis, prognosis, and treatment of colorectal cancer. Our group will concentrate on improving detection and diagnosis of precancerous polyps during colonoscopy. We will use artificial intelligence to teach computers how to automatically recognize and classify the different sub-types of polyps seen through the endoscope. We will also use fluorescent markers to investigate their potential for finding these types of polyps and delineating their margins. The major benefits to be realized are a significant reduction in procedure risks, costs and healthcare burden while permitting more thorough examinations that miss fewer polyps and more selective, complete polyp removal, thus decreasing cancer risk.